NUTRITIONAL MODULATION OF NEWBORN MONONUCLEAR CELL RESPONSES

To explore monocyte functions and cytokine release and production in malnourished and premature infants. We will also examine whether nucleotide supplementation improves cellular responses.